Enhancing Enrollment for NOD and DETECT studies of the Consortium for the Study of Chronic Pancreatitis, Diabetes, and Pancreatic Cancer

Project Summary/Abstract The Stanford Unit is part of the Consortium for the Study of Chronic Pancreatitis, Diabetes and Pancreas Cancer (CPDPC), which has 4 signature protocols including the PROCEED, INSPIRRE2, DETECT, and NOD study. Our Clinical Center has actively enrolled participants in all 4 studies. The purpose of this administrative supplement request is to increase enrollment primarily in the NOD and secondarily in the DETECT studies by adding an additional full-time Clinical Research Coordinator to boost enrollment of participants and a part-time Laboratory Science Technician to help process and bank samples according to the current protocols.

Public health relevance
Project Narrative Chronic pancreatitis has no cure, is associated with significant disability, and a higher risk of diabetes and pancreas cancer. By aligning our resources with several other clinical centers to form a consortium, we propose to pursue further studies regarding the role of the immune and hormonal system in chronic pancreatitis. These may lead to new insights into understanding how chronic pancreatitis progresses and complications develop including diabetes and pancreas cancer. New diagnostic tests and treatments can subsequently be developed and then validated by this consortium. This administrative supplement is to increase enrollment by hiring additional clinical and laboratory research staff.